Topical Eyedrops Increasing Lysyl Oxidase Activity to Control Myopia

Project Summary
Pediatric myopia, also known as nearsightedness, is an eye condition in which one is unable to bring distant
objects into proper focus. It is the leading cause of vision impairment in the world. The estimated economic
impact of uncorrected refractive error is estimated to be a loss of $202 billion of global gross domestic product.
The prevalence of myopia and high myopia are increasing globally at an alarming rate, with significant increases
in the risks for vision impairment from pathologic conditions associated with high myopia, including retinal
damage, cataract and glaucoma. In 2000, the prevalence of myopia did not exceed 50% in any of the regions
but, by 2050, the prevalence will be ≥ 50% in 57% of the countries, if current trends continue.
We propose a novel topical eyedrop, IVMED-85, for treating myopia. It is a first in class medication that
upregulates lysyl oxidase to pharmacologically induce scleral and corneal crosslinking and stiffening.
Our central hypothesis is that the topical copper eyedrop treatment may enable a non-invasive, simple to use,
and relatively cost-effective treatment for myopia by pharmacologically inducing scleral and corneal collagen
crosslinking.
We provide the first evidence that our proprietary IVMED-85 eyedrops induce biochemical crosslinking and
biomechanical stiffening in cornea and sclera and reduced refraction and vitreous depth in guinea pig myopic
model (Preliminary results). In this project, we will test safety of IVMED-85 in rabbits (Aim 1) and further elucidate
efficacy and duration of effect after cessation in tree shrews, a para-primate model. Our plan is to achieve the
feasibility results of safety and efficacy from this proposed Phase 1 project to plan for a Phase 2 SBIR assessing
optimal duration in primates and GLP toxicology.

Public health relevance
Project Narrative Myopia is a burgeoning worldwide epidemic and is associated with significant increased risks for retinal degeneration and detachment, open angle glaucoma, and cataracts. Treatments that are currently available for myopia include spectacle lenses, contact lenses, and off-label pharmaceutical agents (Atropine). We propose to develop IVMED-85, a novel topical eyedrop, that stiffens the sclera and cornea, (thereby reducing lengthening of the eye), as a disease-modifying agent to slow the progression of pediatric myopia.